Targeting chemoresistant prostate cancer with novel EED inhibitors

Docetaxel is the first-line chemotherapy for metastatic castration-resistant prostate cancer (PCa), the major
cause of PCa mortality. Unfortunately, in most cases PCa develops docetaxel resistance and continues to
progress, which has no cure. Our recent studies (Theranostics, 2021, May 8; 11: 6873-6890) have provided
strong evidence demonstrating that chemoresistant PCa cells rely on an active EED-EZH2-Stat3-SKP2-
ABCB1/survivin signaling to survive and evade standard chemotherapy. In this R01 project, we hypothesize
that targeting EED-EZH2 interaction with novel EED inhibitors is effective to overcome chemoresistance and
eliminate lethal PCa cells. In Aim 1, we will conduct rational design and chemical optimization of novel EED
inhibitors. A total of 200 new chemical entities will be designed and synthesized. In Aim 2, We will validate the
mechanism of action of potential leads in chemoresistant PCa cells. We will identify the in vitro and in vivo
activities of new EED inhibitors against chemoresistant PCa in multiple, heterogenous preclinical models of
chemoresistant PCa. In Aim 3, we will conduct Good Laboratory Practice (GLP) and non-GLP studies to
evaluate the drug-like properties of lead compounds, including pharmacokinetics, absorption, distribution,
metabolism, and excretion (ADME), single- and repeat-dose toxicity and safety pharmacology. With successful
accomplishment of this project, we expect to identify 1~2 patentable lead compounds and advance them into
further preclinical and clinical development. The overarching goal is to translate our basic research into an
effective and safe treatment for lethal PCa, therefore benefiting patients and improving clinical outcomes.

Public health relevance
Chemoresistant prostate cancer (PCa) is lethal with no cure. This R01 project will develop a novel class of EED inhibitors that interrupt EED-EZH2 interaction and block noncanonical EZH2 survival signaling in chemoresistant PCa cells. We anticipate to identify several patentable, highly potent and efficacious EED inhibitors with optimized pharmacological profiles and drug-like properties, which can be promptly moved to the next stages of drug development. This project is original, innovative and has high impact on both translational research and patient care.